Engineering Multi-Cellular Living Systems

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Engineering Multi-Cellular Living Systems
organized by Drs. Roger D. Kamm, Nuria Montserrat Pulido, Jianping Fu. The conference will be held in
Keystone, Colorado from April 3-6, 2022.
Developing the capability to design, engineer and produce complex, multi-cellular engineered living systems
(M-CELS) to emulate natural processes (development, regeneration, and disease) or to create new
functionality is a grand challenge facing the scientific community. The manufacturing and design of these
complex multicellular machines and systems (e.g., organ-on-chip models, biological robots, and organoids)
require fundamental understanding of interactions between cells and their environment, their control by
biochemical and mechanical cues, and coordinated behavior of functional cell clusters through computational
and experimental methods. Cell interactions, controls across scales (from subcellular structures to multi-
cellular systems) and behaviors will be central themes of the conference. The primary aim of this conference
is to bring together a multidisciplinary group of forward-looking researchers seeking to explore these complex
biological interactions and the emergent behaviors they produce, with the goal of creating responsibly
engineered multi-cellular systems with specific functions.

Public health relevance
PROJECT NARRATIVE Multi-cellular engineered living systems (M-CELS) are purpose-driven living systems with multiple interacting living components. They are engineered for specific goals or functions but take emergence into account during the design process, allowing the final system to arise through natural and non-natural biological processes. Therefore, this conference will stimulate cross-disciplinary collaborations by providing a setting conducive to focused, intense discussion among scientists with broad interests at the interface of developmental biology, organoids, medicine, engineered living systems, and ethics.